Structural Dynamics at LCLS

ABSTRACT: ADMINISTRATION AND MANAGEMENT
The proposed BTRR is a collaboration between staff of the Linac Coherent Light Source (LCLS)
and the staff of the existing Structural Molecular Biology (SMB) Resource at the Stanford
Synchrotron Radiation Lightsource (SSRL). The proposed BTRR will be managed as a single
resource under the existing LCLS organization. It will be comprised of three TR&D projects that
will be centrally driven by an evolving portfolio of Driving Biomedical Projects (DBPs). Guidance
from an External Advisory Committee (EAC) as well as from a local Executive Committee will be
an integral part of the strategic planning of the Resource. The proposed BTRR spans the use of
two existing X-ray facilities at SLAC and beamtime award will follow established processes for
each lightsource, with each having separate Proposal Review Panels comprised of external
experts that make recommendations to the respective management of each lightsource.
The proposed BTRR will strengthen an already strong collaborative effort between SSRL-SMB
and LCLS staff. The synergies between the two SLAC lightsources have been exploited for years
with collaborative developments on sample delivery systems for rapid scanning, as well as
common pursuits of liquid jet delivery capabilities and operations. For the proposed BTRR, SMB
staff will take leading roles in some of the TR&D efforts and be involved in all aspects of the BTRR
from strategic planning to technical decisions. SMB is in itself a funded Resource. The proposed
BTRR will create a separate Resource that will leverage the experience and expertise of existing
and future SMB staff. SMB staff will be part of the proposed Resource in a matrixed fashion,
functionally reporting to the BTRR management while administratively continuing to report to
SMB. Central to the coordination of these efforts will be the direct involvement of SMB in strategic
planning for the proposed BTRR. This will ensure staff working on the proposed BTRR are fully
integrated within the proposed BTRR efforts.
The Administration and Management component of this proposal will include the creation of an
External Advisory Committee as well as a Local Executive Committee which will help provide
guidance to the BTRR management team. Administrative and financial management support will
be provided for the BTRR via this component.

Public health relevance
NARRATIVE: ADMINISTRATION AND MANAGEMENT A narrative is not required for this component of the proposal.